Control of lung alveolar regeneration by Dot1L/H3K79 methylation

PROJECT SUMMARY
The multiple tissue compartments or niches in the respiratory system display varying abilities to repair and
regenerate after acute injury or in chronic disease states. The alveolar niche is critical for gas exchange as well
as acting as a sentinel for environmental stimuli including infectious organisms and pollutants. Much of the
regenerative power of the alveoli rests within the alveolar type 2 (AT2) cell, which is not only critical for surfactant
production and innate immune responses, but also harbors the resident progenitor cell population. A building
body of research has shown that subsets of AT2 cells can proliferate and differentiate into alveolar type 1 (AT1)
cells after acute injury, which is critical for regenerating functional alveoli. These AT2 cells behaviors are
regulated by signaling, transcriptional, and epigenetic mechanisms that have only recently started to be
elucidated. To further our understanding of the role that epigenetic pathways play in lung alveolar regeneration,
we performed a small molecule screen using an alveolar organoid assay to identify pathways that promote
alveolar repair and regeneration. This screen identified multiple inhibitors of the Disruptor of Telomeric Silencing-
1 like (Dot1L) that regulate alveolar organoid size. Dot1L is the sole enzyme which is known to methylate H3K79
(H3K79me1/2/3 marks), and Dot1L has been demonstrated to play critical roles in promoting pluripotent stem
cell reprogramming, and cellular responses to injury and tissue regeneration. Our data show that Dot1L inhibition
increases alveolar organoid size in a dose dependent manner. To better understand the role of Dot1L in lung
development and regeneration in vivo, we generated a Dot1L conditional knockout mouse allele and inactivated
Dot1L during lung development and in multiple models of lung injury and regeneration. Loss of Dot1L during
lung endoderm development results in the loss of H3K79 methylation and premature or enhanced expression of
AT1 and AT2 marker genes, suggesting acceleration of AT1 and AT2 cell differentiation. In two models of lung
alveolar regeneration, loss of Dot1L in AT2 cells results in dramatic acceleration of AT2-AT1 differentiation after
lung injury. Single cell RNA-seq (scRNA-seq) combined with ChIP-seq analysis reveals that loss of Dot1L leads
to the emergence of a new AT2 cell state characterized by a dramatic increase in the expression of the important
transcriptional regulators Id1 and Id2 as well as an overall increase in expression of metabolism genes related
to oxidative phosphorylation (OxPhos). Taken together, our data lead to the hypothesis that Dot1L plays an
important role in regulating lung alveolar responses to acute lung injury by regulating the lineage barrier between
AT2 and AT1 cells via de-repression of the critical transcriptional regulators Id1/Id2 and a switch to OxPhos
metabolism, resulting in acceleration of AT2-AT1 differentiation.

Public health relevance
PROJECT NARRATIVE Repair and regeneration of the lung alveoli are essential to restore the ability of gas exchange after lung injury. The molecular pathways that drive this process are poorly understood. The current proposal seeks to characterize a newly identified epigenetic and potentially druggable process that regulates how cells differentiate and reprogram from one state to another.